Dynamics of Fungal Stress Responses in the Host Environment

SUMMARY
Fungi can adapt and grow in a wide range of quickly changing environments, especially under harsh conditions
inside a host. However, the fundamental mechanisms underlying fungal fitness and survival inside a host
remain poorly understood. Stress responses during host colonization are relevant to human health, since
pathogenic fungi with activated stress-responses are better colonizers and less susceptible to antimicrobial
treatments. This results in more than 1 million deaths associated with fungal diseases each year globally.
Along with antifungal compounds, these species have also evolved and adapted to elevated temperature
(37oC), low O2 level, elevated CO2 level, and other stresses derived from the host immune system. This
phenomenon raises several fundamental questions. How do fungi adapt and grow within a host’s environment
during colonization? What are effects of the host immune system on fungal fitness, and how do fungi respond
against these stimuli? Finally, how do shifts in growth environment, and negative effects of the immune system
and antifungal compounds, have an impact on fungal plasma membrane biology? The proposed research
program tackles these questions by taking advantage of the fungus Nakaseomyces glabratus as a tractable
model organism. With the uses of fungal genetics, molecular biology techniques, next-generation sequencing,
proteomics, lipidomics, and an in vivo mouse model, these studies will yield a new and more mechanistic
understanding of how fungal cells sense and adapt to environmental stress during host colonization. The
results will have broad implications for understanding the basic principle of stress response across many
biological systems. They will also bring forth foundational knowledge that will be useful for human health
improvement, in terms of future antifungal development and diagnostic strategies targeting environmental
stress sensing and response.

Public health relevance
NARRATIVE During host colonization, fungi can survive a wide range of environmental insults, including host immune responses, exposures to antifungal compounds, and drastic shifts in growth conditions. A thorough understanding of fungal stress responses will reinforce efforts to govern unwanted fungal growth. The objectives of this proposal are to define fundamental mechanisms of fungal stress responses during host colonization at the genetic level and beyond.